ULTRAVIOLET RAMAN STUDIES OF PROTEINS AND NUCLEIC ACIDS

UV resonance Raman (RR) techniques will be developed for application to structural aspects of nucleic acids and proteins, which underlie their biological function. Novel H-bond patterns will be examined in nucleic acids, including third strand interactions in triple helices and mispaired bases in oligonucleotide duplexes. Ribonuclease A folding mechanisms will be evaluated through direct monitoring of the proline isomer population, and neurophysin conformation changes associated with the binding of hormone peptides will be investigated. A transient UVRR study of bacterial photoreaction centers will be undertaken in order to elucidate the protein dynamics associated with photo-initiated electron transfer.